QBSafe: a randomized trial of a novel intervention to improve care for people living with type 2 diabetes.

PROJECT ABSTRACT: Clinical guidelines, performance measures, and clinical trials for patients with type 2
diabetes mellitus (DM2) have traditionally focused on achieving certain levels of glycemic control. Yet, when
glycemic control is the main focus of diabetes care, important aspects of patients’ health and wellbeing may be
overlooked or undervalued. For patients with poor glycemic control, clinicians typically respond by intensifying
the regimen, all too often without attention to the workload this imposes on patients, their capacity to carry out
the treatment plan, or the contextual factors involved. As a result, diabetes and its treatment may disrupt and
interfere with valued activities and interests (i.e., cause worsening “illness intrusiveness”), and actually worsen
how a person feels or functions. The goal of our program is to promote a paradigm shift in DM2 care: from
reaching HbA1c targets to a whole-person approach that responds to the situation of each patient and reduces
illness intrusiveness. Here, we propose to test a novel intervention to treat DM2 focused on Quality of life,
Burden of treatment (medication administration, costs, and monitoring), Safety (reducing adverse effects), and
Avoidance of Future Events (acute and chronic diabetes complications) – the QBSafe approach. We have
previously developed an Agenda Setting Kit (ASK) for patients to use during their routine office visits. The ASK
is comprised of (a) a set of conversation cards designed to enable patients to identify aspects of QBSafe that
are pertinent to their situation and to share them with their clinician to obtain their input; and (b) materials that
help clinicians respond to patient concerns. We propose to conduct a clustered randomized trial at a
federally qualified healthcare center in New Haven, CT, and to randomize 10 primary care clinicians and 144 of
their patients with DM2 and HbA1c >8% to receive usual care with or without QBSafe ASK in order to achieve
the following: Aim 1: To determine the feasibility of the research procedures necessary to conduct a practice-
based randomized trial to determine the clinical effectiveness of QBSafe ASK in the care of patients with DM2.
Aim 2: Since a definitive trial will require some mechanistic evidence of efficacy, we will power this trial to also
estimate the extent to which usual care with and without QBSAFE ASK can improve: Aim 2A: Patient-reported
outcomes, principally illness intrusiveness (Illness Intrusiveness Rating Scale), as well as diabetes distress
(Diabetes Distress Scale), treatment burden (Treatment Burden Questionnaire), hypoglycemia, and global
quality of life (1-item analogue scale) at 6 months after the intervention. Aim 2B: Clinical outcomes measured
as change in HbA1c between baseline and 6 months. Aim 2C: Patient-centered diabetes judged by (a) rating
the audiovisual recordings of clinical encounters (including the time spent total and in discussing QBSafe
domains), and (b) patient satisfaction (using the ambulatory CAHPS survey) and clinician satisfaction (using
post-encounter survey) with how the encounter went. This work will provide necessary preliminary data for a
multicenter randomized trial to determine the clinical effectiveness of QBSafe ASK in diabetes care.

Public health relevance
PROJECT NARRATIVE: Glycemic control is often the main of diabetes care, but a singular focus on glycemic control may lead to patients’ overall health and wellbeing being overlooked or undervalued. We have previously developed an intervention comprised of (a) a set of conversation cards designed to enable patients to identify aspects of life with diabetes important to them and to share them with their clinician to obtain their input; and (b) materials that help clinicians respond to patient concerns. We now propose to conduct a randomized clinical trial to test the feasibility of the research procedures and efficacy of the intervention with respect to patient reported outcome measures and for improving glycemic control.